A Novel Wild-derived Diversity Mouse Population for Precision Mapping and Systems Genetics

PROJECT SUMMARY
Inbred mouse strains are integral tools for both preclinical and basic research. While the absence of genetic
diversity is a widely perceived strength of inbred strains, it is also a critical limitation, as a single inbred genetic
background cannot capture the full spectrum of phenotypic responses observed in genetically diverse human
populations. This limits the translation success from inbred mouse models to human clinical outcomes and
underscores the need for mouse platforms that more accurately model human genetic variation. The Diversity
Outbred (DO) mouse population was founded in 2012 to meet these crucial research needs. The DO was initiated
from eight genetically diverse inbred mouse strains, including wild-derived representatives from each of three
cardinal house mouse subspecies, and has been maintained by pseudo-random mating for over 50 generations.
However, the inclusion of founder strains derived from reproductively isolated subspecies has, over time,
exposed genetic incompatibilities and unchecked selfish elements, resulting in allele frequency distortions that
have compromised the genetic integrity of the DO. Here, we propose to generate a new, high diversity outbred
mouse population, the Wild Mouse Diversity Panel (WMDP), founded from novel wild-derived inbred strains of
single subspecies origin (Mus musculus domesticus). Our recent work has shown that a large proportion of
variants in the genomes of these newly developed M. m. domesticus strains are absent from existing inbred
mouse strains, and that these strains capture novel neurobehavioral, metabolic, physiological, and biochemical
phenotypes not observed in common laboratory mouse models. Thus, the WMDP stands to minimize potential
haplotype distortion due to genetic incompatibilities between subspecies, allow functional assessment of millions
of variants that have never been tested in the laboratory, and empower investigations of natural genome
complexity. In Aim 1, we will initiate an outbred population from four phenotypically and genetically diverse wild-
derived M. m. domesticus inbred strains, implementing routine genomic monitoring of allele frequencies to
ensure the genetic integrity and longevity of the WMDP resource. To aid discovery efforts in this new population,
we will generate key genomic resources for the founder strains in Aim 2, including high quality de novo genome
assemblies, comprehensive variant call sets, and a gene expression atlas of several tissues. In Aim 3, we will
provide a proof-of-principle study to underscore the power and utility of the WMDP. We will profile phenotypic
diversity for several morphological, metabolic, behavioral, and clinical traits in early outbreeding generations of
the WMDP, map causal loci, and integrate our findings with human data to identify human-mouse translational
parallels at the levels of both genes and gene networks. This project will yield a new outbred mouse population
poised for near limitless discovery in all areas of basic and preclinical research. This resource will become part
of the Special Mouse Strain Resource at The Jackson Laboratory, which will provide the framework and setting
for its long-term maintenance and distribution to the global research community.

Public health relevance
PROJECT NARRATIVE Despite their prominence in biomedical research, most studies that use inbred mice to model human diseases ultimately fail to improve treatment outcomes for human patients. This failure likely owes, at least in part, to the fact that inbred laboratory mice do not reflect the genetic diversity of human populations, and therefore stop short of accurately modelling individual heterogeneity in disease etiology and treatment response. To overcome these limitations of inbred laboratory mice, this project will generate a new, genetically diverse mouse population that mirrors the genetic complexity of human populations and that will serve as a powerful live-animal resource for numerous areas of biomedical research, including toxicology, preclinical drug testing, gene mapping, and systems genetics.